Single molecule localization microscopy via angstrom-scale three-dimensional imaging of electron spin labels

Summary
The ability to determine the three-dimensional location of ﬂuorescently labeled biomolecules in cells with 10 to 70
nm resolution has led to an explosion of discoveries in biology. Super-resolution optical microscopy has led to recent
dramatic breakthroughs in our understanding of the organization of molecules in a wide variety of protein assemblies
and has led to discoveries of new supramolecular architectures present in organelles. The spatial resolution typically
achieved by super-resolution optical microscopy remains, frustratingly, considerably larger than most biomolecules.
The goal of this technology development proposal is to create a technology for localizing individual biomolecules
with angstrom precision. We propose a technology for localizing molecules using spin labels. The proposed work
will employ a magnetic resonance force microscope, in which an attonewton-sensitivity cantilever with a 100
nanometer diameter magnetic tip is operated near a sample surface in high vacuum at cryogenic temperatures.
The magnet-tipped cantilever serves two roles. It acts as a force-gradient detector, enabling the observation of
magnetic resonance from individual electron spins as a shift of the cantilever's mechanical resonance frequency. It
furthermore provides a source of magnetic ﬁeld gradient, 5 gauss/angstrom or larger, that makes possible the three
dimensional magnetic resonance imaging of individual electron spin labels with angstrom spatial resolution. Proof-
of-concept data has been acquired demonstrating the ability to detect magnetic resonance from 100's of nitroxide
spin labels and to spatially resolve electron spin density at a resolution 100 times smaller than the diameter of the
magnetic tip.
We present a stepwise technology development plan — backed by theory, simulations, and preliminary data
— for achieving the detection of individual nitroxide spin labels and imaging their locations in three dimensions
with angstrom precision. Proposed innovations include achieving near-unity spin polarization by operating at high
magnetic ﬁeld and low temperature using novel cryogenic chip-scale microwave sources, employing better inter-
ferometric cantilever position detectors and spin modulation schemes to evade sample-related noise, harnessing
synchronized cantilever and spin excitation pulse sequences to achieve high ﬁdelity spin modulation, developing
robust Bayesian image collection and reconstruction protocols, and fabricating improved cantilevers and magnetic
tips for increased per-spin sensitivity. The technology will be validated using well characterized nucleic-acid rulers,
biomolecules, protein complexes, and antibodies. Proof-of-concept experiments will be carried out to demonstrate
the applicability of the technology to ﬂash frozen biological samples and the ability to carry out correlative ﬂuo-
rescent localization experiments. Taken together the proposed work represents a new technology for localizing an
individual (spin-labeled and ﬂuorescently labeled) biomolecule in a ﬂash-frozen cell with angstrom precision.

Public health relevance
Public Health Relevance/Narrative The goal of this technology development proposal, “Single molecule localization microscopy via angstrom-scale three-dimensional imaging of electron spin labels”, is to create a technology for localizing individual biomolecules with angstrom precision using spin labels. This technology would allow one to determine how biomolecules are arranged in single copies of complex biomolecular assemblies. The molecular machines that carry out biological processes such as transcription, translation, signaling, and locomotion are complex assemblies comprised of mul- tiple biomolecules. The ability to determine the structure of these assemblies at the single molecule level would signiﬁcantly accelerate eﬀorts to understand — and design interventions for — a broad spectrum of biological processes, disorders, and diseases.